Gene Therapy for Idiopathic Parkinson's Disease

There is no cure or disease-modifying therapy for patients diagnosed with idiopathic Parkinson’s Disease
(idPD) that carry no genetic mutations and have no family history of this devastating neurodegenerative
condition. Mark Therapeutics (MarkTx) is addressing the unmet needs of idPD patients by developing a
first-in-class disease-modifying gene therapy that can halt disease progression in this largest group of
Parkinson’s patients (~80% of all cases). MarkTx’s solution is to use an Adeno-Associated Viral (AAV) gene
therapy tailored specifically to idPD patients, which will compensate for the epigenetic loss of expression of a
specific protein in these patients, restore critical cellular functions in dopaminergic (DA) neurons and halt their
pathological loss. Using our first experimental candidate (Mark101), we obtained proof-of-concept for efficacy
and safety of MarkTx’s gene therapy and demonstrated that one-time AAV-driven expression of functional
PLA2g6L protein can stop pathological loss of DA neurons in substantia nigra, and significantly slow progression
of motor dysfunction in preclinical idPD-like aging mouse model. Intellectual property of MarkTx is secured by 4
issued patents and an exclusive license from Boston University.
MarkTx is seeking SBIR Phase I financing to perform feasibility studies and rigorous preclinical optimization
/validation of the improved candidates for Mark’s therapy. The specific Aims of Phase I are:
Aim 1: Optimization and initial testing of new (improved) AAV candidate constructs.
Aim 2: In vitro validation of therapeutic potential of best candidates in human DA neurons.
Aim 3: In vivo treatment optimization and validation of PLA2g6L delivery to DA neurons in live animals.
MarkTx’s team has strong scientific and business experience and is fully qualified to achieve all the goals of
the current proposal. Successful completion of Phase I will identify the best therapeutic candidate(s) for MarkTx’s
gene therapy, validate their ability to express PLA2g6L and restore critical cellular function in DA neurons that is
being lost in idPD patients. Achievement of well-defined milestones will further de-risk MarkTx therapy and
ensure effective transition to SBIR Phase II. NINDS/SBIR funding is essential for development and eventual
commercialization of MarkTx’s highly promising, first-in-class disease-modifying gene therapy tailored
specifically for idPD patients. We strongly believe our innovative therapeutic approach to idPD will be a game-
changer and a major step towards ultimate victory in the fight against this currently incurable and devastating
disease in aging humans. The goals of MarkTx’s proposal fully align with the mission of the NINDS.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Bolotina, Victoria Project Narrative: Currently, there is no cure and no therapy that can halt progression of devastating Parkinson’s disease. Mark Therapeutics proposes SBIR Phase 1 preclinical studies of the new candidates for a first-in-class gene therapy that can stop pathological loss of dopaminergic neurons and significantly slow down progression of disease in idiopathic Parkinson’s patients. This project aligns with NINDS objectives and addresses the unmet medical needs of the largest group of Parkinson’s patients. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page